The alterations caused by obese extracellular vesicles on colorectal cancer tumor microenvironment

Project Summary
Colorectal cancer (CRC) patients with a high body-mas index (BMI) have poor efficacy to chemotherapy, creating
an urgent need to design targeted therapy for this group of cancer patients. During obesity, the excess visceral
adipose tissue (AT) deposited around major organs in the abdomen triggers systemic metabolic dysregulation
and creates an environment conducive to cancer development, particularly colorectal cancer (CRC). Obese AT
secretes more extracellular vesicles (EVs) compared to non-obese AT, which can be taken up by distant tissues.
EVs are lipid-membraned vesicles that carry cargo from the parent cell and are important for inter-organ
communication. Unbiased proteomic analysis revealed that obese EVs (OB-EVs) and non-obese (N-OB) EVs
are distinctly different in terms of their cargo, with an enrichment of the glycolytic enzyme triose phosphate
isomerase 1 (TPI1) in OB-EVs. Consequently, OB-EV treatment of CRC cells resulted in higher TPI1 levels
compared to N-OB EV treatment. Functionally, OB-EVs increased basal glycolysis of human and mouse CRC
cells and enhanced the ability of CRC cells to form 3D tumoroids and spheroids. CRC cells can aberrantly
increase glycolysis to support tumor growth and aggressive, however, it is not known whether these pro-
tumorigenic effects can get enhanced during obesity.
In the F99 portion of this grant, I will determine if the cargo from AT-derived EVs is utilized by CRC cells
to change their metabolism and promote a pro-tumorigenic phenotype, and whether it is enhanced during obesity.
I will use a novel mouse model of intestinal tumorigenesis lacking EV secretion from adipocytes that will be
challenged with obesity to elucidate the role of OB-EV cargo in CRC development. The goals of this project are
to 1) confirm whether OB-EVs transfer TPI1 to CRC cells and its regulation on glycolysis and 2) determine the
oncogenic role of OB-EV and TPI1 in CRC development in vivo. The results from this study will help advance
the field of EV biology in cancer during obesity and identify potential targets for cancer therapeutics in obese
CRC patients.
In the K00 portion of this grant, I will expand on elucidating the impact of AT-derived EVs on the immune
population of CRC TME. Obese CRC TME is known to be immunosuppressive with increased infiltration of M2-
like macrophages. However, there is a lack of studies enumerating the underlying molecular players mediating
the observed phenotype. Therefore, I propose to determine whether OB-EVs reprogram macrophages in the
obese TME to an immunosuppressive M2-like phenotype to promote tumor progression. I will seek K00 labs with
comprehensive expertise on tumor immunology and associated signaling pathway to provide me with the training
I require to complete my project and characterize the impact of obesity in CRC TME.

Public health relevance
Project Narrative Obesity increases the risk of colorectal cancer (CRC) development in both men and women by changing the tumor micronevironment. This proposal will identify signaling molecules that are responsible for promoting tumor development during obesity and determine potential targets for cancer therapy for CRC patients with an obese body mass index.